GENERATION OF GENETIC SUPPRESSOR ELEMENTS AGAINST HIV

Somatic gene therapy of bone marrow stem cells has been proposed as an alternative to conventional therapies of AIDS. Successful inhibition of HIV replication using ribozymes, antisense oligonucleotides, RNA-decoy strategies and dominant-negative mutants has been reported. We have developed a new technology for the efficient generation of genetic suppressors represented by antisense RNA and dominant-negative mutants. It is based on the functional selection of genetic suppressor elements (GSEs) from a random fragment library generated from a gene or a genome of interest. This approach has been validated in two model systems: The selection of GSEs, derived from the lambda phage genome, that conferred bacterial resistance to phage-mediated lysis and-also the isolation of USEs from the human topoisomerase II gene which conferred etoposide resistance to human cells. We have generated USE libraries from the HIV-l genome and have selected putative USEs capable of protecting human cells from HIV-mediated cytopathicity. The aim of this proposal is to fully characterize the current pool of anti-HIV USE candidates by further selection and to also develop an alternative GSE selection procedure that will address limitations identified in preliminary studies. In addition, we will evaluate "GSE-cassettes" containing multiple, characterized, anti-HIV elements that inhibit different stages of the viral life cycle. This proposal will identify potential candidates for somatic gene therapy of HIV infected cells. PROPOSED COMMERCIAL APPLICATION: We have developed a new technology for the efficient generation of genetic suppressors represented by antisense RNA and dominant-negative mutants. It is based on the functional selection of genetic suppressor elements (USEs) from a random fragment library generated from a gene or a genome of interest. The aim of this proposal is to fully characterize the current pool of anti-HIV USE candidates by further selection and to also develop an alternative USE selection procedure that will address limitations identified in preliminary studies.